Papillomavirus Bioinformatics Resource

The PapillomaVirus Episteme (PaVE) has been established to provide information and bioinformatics resources to the scientific community for research on the Papillomaviridae family of viruses. The PaVE consists of a relational database and web applications that support the storage, annotation, analysis, and exchange of information. As much as possible, the PaVE adopts an Open Source software approach and emphasizes the integration and reuse of existing tools. A major update of PAVE was released in July 2011 and can be found at http://pave.niaid.nih.gov.